Thalamic microglia drive cognitive impairment after cortical injuries

ABSTRACT
Traumatic brain injury (TBI) increases the risks for cognitive impairment and dementia, such as Alzheimer’s
disease and Alzheimer’s disease-related dementias (AD/ADRD). Multiple human imaging studies of the brains
after traumatic brain injury reported the signs of prominent microglial activation in the thalamus that highly
correlates with cognitive impairment. Nevertheless, the role of thalamic microglia in cognitive impairment after
TBI remains unclear. We have recently discovered a unique role of thalamic microglia in cortical injury-induced
recognition memory deficits in mice. Our preliminary studies demonstrated that local depletion of thalamic
microglia, not hippocampal microglia, counteracted recognition memory deficits. Thalamic microglial depletion
also improved thalamic neuronal survival and restored c-Fos expression in multiple recognition memory-related
brain regions, including the medial prefrontal cortex (mPFC), hippocampus (HPC), and perirhinal cortex (PRh).
Local activation of thalamic neurons restored recognition memory deficits, highlighting a primary role of
thalamic neuropathology in the behavioral phenotype. Our single-cell RNA sequencing (scRNA-seq) data
revealed the development of microglial subtypes in the thalamus, including the one with high phagocytic
capability. Consistent with the molecular findings, the thalamic microglia in the injured brains engulfed neurons
and inhibition of phagocytosis attenuated recognition memory deficits in the injured mice. These data suggest
that thalamic microglia may promote recognition memory deficits by damaging neurons and synapses. Thus, in
the proposed study, we will test our hypothesis that excessive microglial phagocytosis in the thalamus after
cortical injuries damages neurons and synapses, causing cognitive impairment. We will use a well-established
cortical controlled impact (CCI) model in mice. In Aim 1, we will elucidate cortical injury-induced microglial
changes and their effects on neurons in the thalamus. In Aim 2, we will demonstrate that removal of thalamic
microglia has an immediate restorative effect and a long-term ameliorative effect on recognition memory in the
injured mice. In Aim 3, we will evaluate the effects of microglial phagocytosis inhibition on thalamic neuronal
pathology and cognitive impairment after cortical injuries. Together, this study will assess the role of thalamic
microglia phagocytosis in cognitive impairment after cortical injuries. The findings will provide a novel
mechanistic insight into the critical thalamic pathology underlying TBI-induced long-term neurological deficits.

Public health relevance
Narrative Traumatic brain injury is a risk factor for cognitive impairment and dementia, such as Alzheimer’s disease and related dementias. This proposal outlines experiments designed to determine the mechanisms of how neuroinflammation, particularly microglia activation, in the thalamus drives cognitive impairment after injury. The findings will create scientific foundations to understand better the link between brain injury and subsequent cognitive impairment.